Project 2: A Novel Cellular Tumor Vaccine Strategy for Glioblastoma

PROJECT SUMMARY – Project 2
Glioblastoma (GBM), the most common malignant brain tumor, has an extremely poor prognosis with a median
overall survival of <21 months. Standard therapies for GBM are largely ineffective. Immunotherapies for GBM
appear to have the greatest potential for success, but are limited by the fact that GBM tumors are poorly
immunogenic. For this reason, effective treatment of GBM will likely require an active immunotherapy such as
vaccination against GBM antigens. Unfortunately, stimulating effective anti-tumor T cell responses in the
majority of patients has proven difficult. While standard tumor vaccination strategies stimulate tumor-specific
cytotoxic T cell (CTL) responses in most patients, they provide very little benefit in terms of tumor progression
and patient survival. We reasoned that the poor efficacy of current tumor vaccines may be due to the fact that
they do not target the pathways by which endogenous CTL responses are generated. Using mouse models,
we identified a novel cellular vaccine strategy that exploits an endogenous Ag presentation pathway. In this
strategy, resident splenic DC are loaded with antigens (Ags) in situ by the intravenous injection of Ag-loaded
monocytes. The administered monocytes migrate to the spleen, transfer Ag to DC for presentation to T cells,
and stimulate robust T cell proliferation, CTL activity, and anti-tumor immune responses that are markedly
superior to that seen with current vaccines. Our preclinical data suggests that this strategy may serve as a
simple and efficacious immunotherapeutic platform for the treatment of human cancers. Here, we will, for the
first time, test this novel cellular vaccine strategy in humans. After optimizing our protocol for the large-scale
harvesting and Ag-loading of human monocytes, we will perform a Phase 1 safety and dose ranging study of
monocyte vaccination in patients with GBM. In this study, increasing numbers of Ag-loaded human monocytes
will be administered to cohorts of patients to determine if and when dose-limiting toxicity occurs and determine
the dose of monocytes that stimulates the maximal Ag-specific T cell response. Once these safety and dosing
parameters have been determined, we will perform an expanded Phase 1 study to confirm the safety of our
optimal monocyte dose and determine its effects in terms of T cell response and potential clinical benefit. This
project represents a first-in-man study to establish proof of principle for an entirely novel cellular vaccine
strategy.

Public health relevance
PROJECT NARRATIVE – Project 2 Glioblastoma (GBM) is uniformly lethal with a median overall survival (OS) of <21 months. Evidence suggests that effective treatment of GBM will require an active immunotherapy to stimulate T cell responses against GBM antigens, but no immunotherapeutic strategy has been identified that can reliably induce clinically effective anti-tumor T cell responses. Here, we will perform the first human testing of a novel cellular vaccine strategy that has shown considerable efficacy in preclinical studies. If successful, these studies will provide proof-of-principle of a novel immunotherapeutic strategy that has the potential to significantly improve the survival of patients with GBM.